National HIV Behavioral Surveillance System

DESCRIPTION (provided by applicant): Due to its geographic proximity to New York City the Nassau/Suffolk metropolitan statistical area (MSA) shares many of the HIV and drug related epidemiologic concerns of Urban MSAs. HIV trends are particularly of concern for young MSM, sexually active females, and Black males who use injection drugs. Individuals who fall into these categories experience rates of HIV that are alarmingly elevated relative to other members of their risk group. Understanding the factors that continue to impede risk reduction among these groups is essential to primary and secondary prevention of HIV. As a complement to traditional HIV surveillance which focuses on data from lab reports and medical providers, behavioral data collected from individuals involved in high risk activity such as men who have sex with men (MSM), injection drug users (IDU), and heterosexuals at risk for infection can augment the broad based information gleaned from traditional sources. Behavioral surveillance can identify certain emerging epidemiological trends, direct intervention efforts on populations most currently at risk, and evaluate whether current intervention goals are being met. As a Behavioral Surveillance grantee, we will conduct annual rotating surveys of the designated high risk groups MSM, IDU, and heterosexuals at risk for infection. For each MSM and IDU cycle a minimum of 500 eligible participants will be enrolled;a minimum of 450 heterosexuals at risk for HIV infection will be enrolled during the heterosexual cycle. To assess the incidence and prevalence of HIV, all cycles of the National HIV Behavioral Surveillance (NHBS) project will include a voluntary HIV testing component. The attached research plan outlines how the activities of each NHBS cycle will be completed. PUBLIC HEALTH RELEVANCE: Nassau/Suffolk has the highest rates of HIV/AIDS in New York State, exclusive of New York City. Local HIV prevalence figures, along with other social science research which denotes large pockets of poverty and social problems among the country's original suburbs contiguous to the largest metropolitan areas, severely discount the assumption that America's suburbs are uniformly 'healthy and wealthy'(Puentes &Warren, Brookings Institute, 2006). Systematic and ongoing assessment of risk behaviors among groups at highest risk of HIV/AIDS provides baseline data to monitor the evolution of infection in Nassau/Suffolk, access to and utilization of prevention services and augments the broad based information gleaned from traditional surveillance methods that focus on data from lab reports and medical providers.

Public health relevance
Nassau/Suffolk has the highest rates of HIV/AIDS in New York State, exclusive of New York City. Local HIV prevalence figures, along with other social science research which denotes large pockets of poverty and social problems among the country's original suburbs contiguous to the largest metropolitan areas, severely discount the assumption that America's suburbs are uniformly 'healthy and wealthy' (Puentes & Warren, Brookings Institute, 2006). Systematic and ongoing assessment of risk behaviors among groups at highest risk of HIV/AIDS provides baseline data to monitor the evolution of infection in Nassau/Suffolk, access to and utilization of prevention services and augments the broad based information gleaned from traditional surveillance methods that focus on data from lab reports and medical providers.